Urology Centers Program Interactions Core (U24)

PROJECT SUMMARY
Critical knowledge gaps in our understanding of benign genitourinary (GU) diseases exist, such as their etiology
and development, pathophysiology, and mechanisms of progression. The phenotypic expressions of many GU
diseases remain undefined, which stymies both basic and clinical research. Clinical challenges include lack of
accurate and objective diagnostic tests for many of these conditions, dearth of effective multidisciplinary and
interdisciplinary approaches to management, impact of current treatments and therapies on comorbid disease
processes and quality of life, and lack of reimbursement for strategies to prevent onset and progression.
Moreover, the true public health burden of GU diseases overall is unknown, and the impact of disparities in
health outcomes is under-appreciated and under-studied. The proposed Interactions Core for the Community
of NIDDK-funded benign GU Centers and Programs known as CAIRIBU (Collaborating for the Advancement
of Interdisciplinary Research in Benign Urology) will foster and support integrated basic and translational
science that answers critical questions in benign GU disease and builds the breadth, depth, and visibility of the
urology research community. Building on our prior successes, we will provide leadership, coordination,
infrastructure, and logistic support for the CAIRIBU research community by identifying and facilitating
opportunities for cross-CAIRIBU collaboration, promoting research findings and resources to the broader GU
research community, and raising the visibility and support for GU research. We will: 1) provide centralized
organization and coordination to leaders, investigators, and trainees in the CAIRIBU Community to enhance
and promote highly meritorious convergent research; 2) develop and nurture research collaborations by
identifying and fostering opportunities for knowledge exchange, resource-sharing, transdisciplinary interaction,
and networking across CAIRIBU and the entire GU research community; 3) increase the research capacity of GU
investigators, particularly of trainees and early-stage investigators; and 4) amplify GUD research by building a
multi-faceted communications, networking, and outreach strategy across the broader urology research
community, among patients, and within the public. Our Interactions Core (IC) is led by an established benign
GU disease investigator who has functioned in the capacity of CAIRIBU IC Director since July 2018, during a 2-
year pilot phase, and then since 2020 after obtaining a competitive award. Due to its multiple resources and
strengths in urology research, the University of Wisconsin is an ideal environment for supporting the IC. The
Department of Urology is ideal for the home of the IC due to its strong commitment to GU research as evidenced
by its ranking within the top five for research funding to urology departments. We will use innovative and
engaging approaches to leverage investigators’ common passion for addressing critical gaps in knowledge in
benign GU disease and building the numbers and diversity of the urology research workforce.

Public health relevance
PROJECT NARRATIVE The overarching goal of the Urology Interactions Core at the University of Wisconsin School of Medicine and Public Health is to foster and support collaborative transdisciplinary research that addresses critical research gaps in our understanding of causes, progression, and personal, societal, and environmental impacts of genitourinary disease and function, including urinary tract infection, urinary tract stones, prostatic enlargement, bladder dysfunction, lower urinary tract symptoms (pain, incontinence, voiding and storage dysfunctions), male reproductive disorders and men’s health, and developmental (congenital) abnormalities of the urinary tract. We will provide centralized research infrastructure to support the leaders and investigators in the National Institute of Diabetes and Digestive and Kidney Diseases Urology Centers Program collectively known as CAIRIBU – Collaborating for the Advancement of Interdisciplinary Research in Benign Urology. Specifically, the Interactions Core will identify and strengthen opportunities for cross-CAIRIBU interactions and collaborations, promote research findings and research resources to the broader urology research community and the public, facilitate the development of the next generation of urology research leaders, and build the community and diversity of benign urology basic, clinical, and epidemiological scientists that study benign urologic diseases.